Oral microbiome and inflammatory status in antimicrobially-treated oral cancer patients

ABSTRACT
The incidence of oral squamous cell carcinoma (OSCC), the most common type of head and neck cancer,
continues to rise among numerous demographic groups in the US, yet its 5-year survival rate has not improved
for several decades. Despite advances in targeted therapy, immunotherapy and other novel adjuvant regimens,
patients with locoregionally advanced and recurrent/metastatic disease continue to have extremely poor
outcomes, underscoring the need for more effective treatments for OSCC, which often goes undiagnosed until
it has reached late stages. Primary risk factors for OSCC include tobacco use, alcohol consumption, and for
oropharyngeal cancers, HPV infection, but cancer incidence is influenced by additional elements such as
anatomic site, patient demographics, and likely the individual’s oral microbiome. Given that cases of OSCC are
increasing despite targeted head and neck cancer prevention efforts in the US such as smoking cessation and
HPV vaccination, there is a strong rationale for exploring other modifiable risk factors that, together with new
therapies, can improve outcomes for patients with OSCC as well as other aggressive head and neck cancers.
The oral microbiome is a complex and dynamic community of commensal organisms that can become
imbalanced (“dysbiotic”) in response to dietary intake, tobacco and alcohol use, and poor dental hygiene.
Dysbiosis can pre-dispose an individual to oral disease, including cancer, by enriching for bacterial pathogens
that promote carcinogenesis, secrete carcinogenic compounds, and promote chronic inflammation. Thus,
reversing oral dysbiosis is a promising approach for protecting against tumorigenesis. The food additive nisin,
which is bactericidal against a broad range of pathogens, has been shown to restore oral microbiome diversity,
suppress inflammation, and stimulate anti-tumor cellular responses in vitro and in a polymicrobial mouse model
of oral cancer, while maintaining its well-established safety profile. However, the potential clinical benefit of nisin
for treating OSCC in humans has not been investigated. Here, we propose a Phase I/IIa trial to establish the
tolerability and feasibility of administering nisin to OSCC patients who represent high-risk populations. In parallel,
we will perform mechanistic studies of nisin and its effects on oral microbiome community structure,
inflammasome expression, and anti-cancer cellular responses of the study participants. We will also analyze the
emergence of nisin resistance among key oral bacteria, which could provide insight into circumventing nisin
resistance in other clinical contexts. We hypothesize that nisin will be well-tolerated among OSCC patients and
will counter dysbiosis by inhibiting bacterial pathogen growth and promoting an anti-tumorigenic environment via
immunomodulation and anti-cancer cell activity. Our long-term goals are to validate nisin as a promising
candidate for OSCC treatment and demonstrate that oral dysbiosis is a major driver of tumorigenesis in humans
that can be manipulated, thus highlighting the important yet mostly unrecognized protective role that
antimicrobials can exert against cancer in humans.

Public health relevance
PROJECT NARRATIVE The food additive nisin has been increasingly recognized for its broad-spectrum bactericidal action and immunomodulatory effects in both animals and humans; however, its clinical benefit in improving outcomes of human oral cancer patients has not been explored. Here, we will conduct a Phase I/IIa trial of nisin in patients with oral squamous cell carcinoma to establish tolerability and feasibility of the treatment regimen. In parallel, we will analyze patient biological samples for nisin-induced changes in oral microbiome diversity, inflammasome expression, and anti-cancer cellular responses, which we predict are the mechanisms through which nisin promotes an anti-tumorigenic environment and protects against oral cancer.